Training Program on Genetic Variation and Human Phenotypes

Project Summary: The Vanderbilt Training Program in Genetic Variation and Human Phenotypes
supports predoctoral students in human genetics. We request funding for 8 predoctoral students,
funded for two years. The mission of this program is to prepare these students for a successful
career in human genetics in an academic, industrial, or public service capacity. We prepare our
students beginning with skills-focused classroom instruction and transitioning to experienced-
based learning through research and active collaboration with more experienced mentors.
Students are regularly exposed to leaders in human genetics research through their
collaborations, research seminars, and attendance at national and international meetings. This
training program has enjoyed broad success, with our students achieving excellent productivity
(mean 5.1, range 2-11, publications during graduate school by recently funded students). Student
excitement for human genetics training has rapidly increased, demonstrated by a 3-fold increase
in the number of students entering the Vanderbilt Human Genetics (HGEN) PhD program over
the past 5 years. Much of that increased excitement has grown from the unprecedented data
available now to students. Previously, it could take years of career advancement to assemble
even a single large-scale cohort of a single phenotype. However, with the advent of large biobanks
with clinical data, cohorts can now be assembled relatively quickly by graduate students with the
proper training, which our program provides. The Vanderbilt HGEN program has been at the
forefront of training graduate students in this new type of research. With Vanderbilt’s own large-
scale biobank (BioVU), and now the Data and Research Center for the NIH “All of Us” program
located in the Vanderbilt University Medical Center, our graduate students have been getting both
hands-on and formal didactic training in this new and groundbreaking type of research. With the
establishment in 2015 of the Vanderbilt Genetics Institute, Vanderbilt has committed substantial
resources for recruitment of faculty in genetics and genomics and additional investment in
genotyping of biobank subjects. Our graduate students are well-rounded biologists, with most
matriculating through the Interdisciplinary Graduate Program (IGP) at Vanderbilt and the rest from
the Quantitative & Chemical Biology Program (QCB). They conduct research in an amazing
variety of topics and publish as graduate students in the top scientific journals. Their education is
clearly empowering them, as the students themselves are major designers of their own
collaborative research within Vanderbilt, and they rightly feel that they are not just benefitting from
the excitement in the field of human genetics today but are also driving it.

Public health relevance
NARRATIVE Our training program in human genetics offers pre-doctoral students the opportunity to learn and apply human genetics science in a highly collaborative and collegial environment rich in resources that can stimulate human genetics research. BioVU, the biobank at Vanderbilt University, for example, has more than 250,000 subjects and past human genetics students have been unusually productive because of the opportunities in conducting human genetic studies in these data. Our students receive a broad-based education and have traditionally pursued a wide range of research in human genetics and professional careers.